NIAID DCR OPERATIONAL TASK ORDERCOVID FUNDING SUPPORTS THE NIAID DCR COVID WEBSITE AND THE VARIANT TESTING SAVE PROGRAM FOR VARIANT TESTING.

COVID SARS-CoV-2 Assessment Viral Evolution (SAVE) variant testing provides support for analysis of SARS-CoV-2 genome sequences from specimens collected in COVID-19 therapeutic and observational trials for genetic variants that could impact diagnostics, therapeutics, vaccine efficacy, and disease severity. Additional genome sequencing will be done at NIAID Special Projects on samples collected from observational studies and for diagnostic purposes. This will broaden the understanding of the circulation of SARS-CoV-2 variants. COVID SAVE provides support for the analysis of the impact of SARS-CoV-2 variants in vitro neutralization assays. Additionally, COVID SAVE variant testing allows analysis of the evolution of SARS-CoV-2 and identification of future variants with potential public health impacts